Ultra-low Fouling and Anti-infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters

PA-20-272, Nytricx, Inc., STTR Phase II – Supplemental - Abstract
“Ultra-low Fouling and Anti-infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters"
(Parent Grant 2 R42 HL149595-02A1)
Nytricx has developed proprietary technology for the prevention of intravascular catheter associated
thrombosis and infection, utilizing the natural properties of Nitric Oxide (NO). The combination of topcoats to
prevent protein adsorption and biofilm formation, coupled with NO gas release from the base silicone
polymer is unique, especially considering that the NO donor itself stays embedded in the polymer, with only
NO gas escaping to affect the external and internal catheter environments. However, the silicone base
polymer would not withstand power injection of contrast material which is delivered at a flow rate of 5 ml/sec
to perform diagnostic CTs (computer assisted tomography). This high flow rate results in maximum pressure
exerted on the catheter wall of 300 PSI.

Public health relevance
PA-20-272, Nytricx, Inc., STTR Phase II – Supplemental - Narrative “Ultra-low Fouling and Anti-infective and Anti-thrombotic Nitric Oxide Releasing Intravascular Catheters" (Parent Grant 2 R42 HL149595-02A1) The objective of the supplemental funding request is to support catheter manufacturing to reinforce the Nytricx intravascular silicone-based catheter with nylon monofilament such that the catheter withstands power injection up to 300 PSI for diagnostic CTs.